Statewide System and Organizational Strategy for Evidence-Based Practice Implementation and Sustainment in Substance Use Disorder Treatment

PROJECT SUMMARY ABSTRACT
The NIH has called for testing promising implementation strategies (PAR-19-274) and there is a critical need for
implementation and sustainment of effective and evidence-based practices (EBPs) to address health conditions
including substance use disorders (SUDs). This proposed project is consistent with NIDA’s Priority Focus Area
“Strategies to improve the effective and sustainable implementation of evidence-based prevention and treatment
interventions (implementation science).” Most implementation strategies do not address the complex multilevel
context for implementation in public service sectors. This proposed project will expand the Leadership and
Organizational Change for Implementation (LOCI) intervention, an innovative organizational change strategy for
EBP implementation and sustainment, to include partnership with a statewide Department of Mental Health and
Addiction (DMHA) and Community Mental Health Centers (CMHCs) in order to align state-level leadership
policies and directives with organizational implementation improvement strategies. SUDs are among the most
complex of public health issues and Indiana ranks as the fourth worst state in providing SUD services with about
8.5% of the population meeting criteria for a SUD, of whom only 13.6% seek treatment. Indiana DMHA
approached the UCSD LOCI team to aid in the implementation of combined Motivational Enhancement
Therapy/Cognitive Behavioral Therapy (MET/CBT) The main innovation in this project is that, consistent with the
Exploration, Preparation, Implementation, Sustainment (EPIS) framework and system and organizational theory,
we will add a system level component to LOCI with the goal of bridging outer and inner context and developing
and aligning a positive implementation climate to support implementation and sustainment of MET/CBT for
SUDs. This project will test an implementation strategy that seeks to align, system, organization, and clinic
leadership and strategies to implement and sustain an EBP for substance use disorders. The Leadership and
Organizational Change for Implementation - System Level (LOCI-SL) seeks to improve implementation
leadership, climate, provider attitudes and behaviors, and EBP fidelity and client engagement in services. LOCI-
SL will be tested in a statewide mental health and addiction service system and its community mental health
centers.

Public health relevance
PROJECT NARRATIVE This project will test an implementation strategy that seeks to align system, organization, and clinic leadership and strategies to implement and sustain an evidence-based practice (EBP) for substance use disorders. The Leadership and Organizational Change for Implementation - System Level (LOCI-SL) seeks to improve implementation leadership, climate, provider attitudes and behaviors, and EBP fidelity for enhanced client engagement in services and outcomes. LOCI-SL will be tested in a large, statewide, integrated mental health and addiction service system through clinics in community mental health centers.